Cancer Control Research Training Curriculum

This is a revised competing renewal of the Cancer Control Research Training Curriculum (CCRTC) R25T from Dr. Gary Morrow of the University of Rochester. The two year training program provides MD and PhD trainees with the tools and experience to establish careers as outstanding independent investigators in cancer control and prevention research who can compete successfully for research funding. Trainees take required lectures, core courses, workshops and seminars in Patient-Oriented Research, Biostatistics and Informatics Research, and Health Outcomes Research to complete a Master of Public Health or a Master of Science degree with a specialization in Clinical Investigation, Medical Statistics or Translational Research. Through the peer-reviewed research of 18 potential mentors from 11 medical center departments, as well as the NCI-funded Community Clinical Oncology Program Research Base, trainees engage actively in transdisciplinary mentored research projects locally and in multiple institutions. Eighty-six applicants (41 males/45 females: 23 MD/63 PhD: 15 minority) were evaluated for our first five classes. Twenty-nine were invited for on-site interviews and 15 of the 20 offered, including 6 minority, accepted positions. Each of the 11 trainees who has participated in the program at least a year has obtained peer-reviewed, investigator-initiated funding, for a total to date of over $7,800,000. Six trainees have received Early Career Research awards from professional associations. Program trainees have submitted 132 separate manuscripts-84 have been published, 21 are in press with the rest under review.

Public health relevance
Morrow, Gary R. Since it began in 2004, our R25 training program has enrolled 15 exceptional postdoctoral trainees for careers in the multidisciplinary arena of cancer control research. Our curriculum requires trainees to complete course work and attend lectures and seminars in the areas of biostatistics and informatics research, patient-oriented research, and health outcomes research. Mentored research projects have focused on smoking cessation, nutrition, cancer screening, exercise and health disparities in underserved populations. In this competing renewal, we propose to strengthen our training program by providing trainees with a broad range of theoretical, methodological and technical knowledge necessary to sustain successful careers in cancer control and prevention research.